Identifying the pathways associated with bacterial antibiotic persistence within host tissues

PROJECT SUMMARY
Residual subpopulations of antibiotic-susceptible bacteria can remain within host tissues following
antibiotic treatment. These surviving bacteria are called persister cells, which are transiently tolerant to high
levels of antibiotic, and can cause serious relapsing infection after treatment. Critically, current treatment
strategies do not target persisters. To fully eradicate all bacterial cells, treatments are prolonged, increasing
patient and clinical costs. Prolonged antibiotic exposure can promote antibiotic resistance, further emphasizing
the need to improve treatment efficacy. Improved treatment strategies would simultaneously target all
members of the bacterial population, including persisters. However, persisters have been primarily studied in
culture, and relevant persister cell-specific drug targets within host tissues are largely undefined. Bacteria
behave very differently in host tissues, where nutrient limitation and antimicrobial host defenses activate strong
stress response pathways in bacterial pathogens. We predict persisters utilize distinct, potentially novel,
survival strategies within the host environment.
To study bacterial antibiotic persistence within host tissues, we established a mouse model of
doxycycline treatment of Yersinia pseudotuberculosis splenic deep tissue infection. Doxycycline is an effective
treatment for human Yersinia infection, but requires 7 days continuous treatment, which has been incorporated
into our mouse model. Prior to antibiotic treatment, Y. pseudotuberculosis replicate to form clusters of
extracellular bacteria that directly interface with a layer of neutrophils that are, in turn, enveloped by a layer of
monocytes. In the initial 4h of doxycycline treatment, we observe a significant decrease in viable bacterial
numbers, which correlates with a wave of neutrophil infiltration into the spleen. However, a residual bacterial
subpopulation (~10%) remain in the spleen throughout the 7-day treatment. Bacterial cells resume growth and
cause lethality when antibiotic concentrations wane, defining these cells as persisters.
We hypothesize that interactions with neutrophils and monocytes predispose persisters to
survive antibiotic treatment, and prolonged antibiotic exposure promotes additional transcriptional
and genetic changes within persister cells. Utilizing our fluorescent reporter system to detect viable,
doxycycline-exposed bacteria within the mouse spleen, we will: 1) identify the transcriptional, proteomic, and
genetic changes specific to surviving bacteria within antibiotic-treated mice, 2) determine whether specific
bacterial targets are critical for antibiotic persistence in the host, and 3) determine if monocyte or neutrophil
interactions promote antibiotic persistence. We hypothesize activated neutrophils initially reduce the bacterial
burden, and we will determine if evasion of neutrophil-mediated killing promotes persister cell survival.
Identifying persister cell survival strategies within host tissues will provide critical information to advance the
field and enable the development of more efficacious therapeutic strategies against bacterial infections.

Public health relevance
PROJECT NARRATIVE Antibiotic treatment failure is becoming a huge public health concern, as current antibiotic treatment strategies frequently result in incomplete elimination of bacterial populations from host tissues. Surviving bacterial cells are known to have reduced antibiotic susceptibility, however, the pathways that promote bacterial survival within host tissues remain unclear and unexplored. This proposal will address this critical knowledge gap by identifying the pathways that promote bacterial survival and determining if directly targeting these pathways with combination therapeutics could significantly improve treatment efficacy.